Core 1: Genomics

ABSTRACT
The mission of the Genomics Core of the Memorial Sloan Kettering Cancer Center SPORE in Leukemia is to
lead the analysis and interpretation of studies investigating the genetic, transcriptional, and epigenetic
mechanisms contributing to AML development and resistance to therapy, and to identify potential therapeutic
synergies and vulnerabilities through the integration of both targeted and unbiased genomic data. Achieving the
transformative advances required for each Research Project to meet its goals will be greatly reliant on access to
cutting-edge bioinformatics expertise. This expertise will be utilized to simultaneously focus a wide range of
genome-wide data types on specific biological questions from each Project while also being broad enough to
capture potentially shared mechanisms of response and resistance between the four Research Projects. Prior
to the initiation of all studies, Core staff will consult with SPORE investigators to discuss the underlying scientific
premise and translational goals of the project, to help the investigators select the ideal genomic techniques,
sequencing parameters, and robust analytical methods. We will also coordinate with the investigators of the
Biostatistics core to estimate sample sizes to ensure adequate power to address study objectives. In laboratory
experiments, Core members will assist in the formulation of the experimental design and in the analysis and
interpretation of the data at the conclusion of the study. For molecular studies using primary human and mouse
tissues, Core members will closely interface with the members of the Biospecimen Repository Core, and will
have primary responsibility for merging molecular and clinical data, and for performing appropriate bioinformatics
analyses. The members of the Genomics Core will also work with SPORE investigators to format data for
publication and assist with deposition of genomic data into public repositories to facilitate validation of results by
external investigators using their own analytical methods. We believe that this experienced and collaborative
Core is well configured to provide the Leukemia SPORE with a high level of bioinformatics leadership and support
that will enhance the quality and quantitative rigor of its science.

Public health relevance
PROJECT NARRATIVE The Genomics Core of the MSK SPORE in Leukemia brings together unique expertise in computational biology and modeling of genomic data to support generation, analyses, and interpretation of data generated in the research projects of the Leukemia SPORE. Our major aims are to deliver mechanistic insights into the biology, disease progression, and treatment response of AML. Our vision is to deliver data-driven and evidence-based research that will guide development of diagnostic biomarkers, disease surveillance tools, and, importantly, biologically-informed therapeutic interventions to include target identification, target validation, and preclinical model development.